Biophysical Mechanisms of Force Transmission in Cytoskeletal Ensembles

Project Summary:
Actin filaments and microtubules are cytoskeletal polymers essential for cell division, motility, and intracellular
transport, and deficiencies in these proteins are implicated in cancer, heart disease, and other disorders. In order
to facilitate vital tasks that span the entire cell, these filaments coordinate with each other through motor proteins,
such as kinesin and myosin, and associated binding proteins. The molecular basis for this communication
through tension and compression forces and how these signals propagate through the cytoskeleton is not well
understood. Approaches to study such cytoskeletal phenomena have traditionally been either at the single
molecule level or whole cell level, and the actin and microtubule cytoskeletons have generally been evaluated
as separate systems in vitro. While single molecule experiments, with methods such as optical trapping, have
been invaluable in deciphering the mechanics of individual motors, a completely reductionist approach with one
filament and one motor protein does not accurately represent the structural hierarchy in which crosslinking
motors and proteins function. On the other hand, cell level studies take place in a quite complex environment. In
this research plan, we will bridge the gap in scale and assay control by engineering novel, physiologically relevant
cytoskeletal environments, or nanocells, in which to probe motor protein mechanics and cytoskeletal crosstalk.
Much like LEGOs, we can choose which cytoskeletal elements to incorporate in our nanocell’s architecture and
tune the building blocks accordingly to understand how changes at the molecular level propagate to system level
force generation and network stiffness. Using this innovative approach, our overarching goal is to provide a
fundamental molecular understanding of how motors, crosslinkers, filaments, and signaling factors communicate
with each other in ensembles and to the local cytoskeletal environment utilizing optical trapping, quartz crystal
microbalance with dissipation, and spectroscopic techniques. Specifically, we will investigate how myosins work
together in ensembles in actin assemblies and what molecular components dictate productive force generation.
Hybrid nanocells that consist of elements from both the actin and microtubule cytoskeleton will be probed to
understand how polymers of different stiffnesses, crosslinking proteins with different pliability, and motor proteins
with varying processivity and force generation capability affect cytoskeletal crosstalk. As E-hooks are the
diversity site of tubulin and uniquely influence motility in disparate kinesin families, we will interrogate how E-
hook structure affects ensemble kinesin force generation in nanocells. The proposed research will pave the way
to our long-term goal, which is not only to understand fundamental mechanisms that sustain life, but ultimately
be able to reconstitute physiologically realistic models of cellular processes in vitro, providing an enormous
potential for developing diagnostic and treatment strategies for cytoskeletal diseases.

Public health relevance
Project Narrative: Coordination of the actin and microtubule cytoskeleton through molecular motors and associated proteins is essential for performing vital large-scale cellular tasks such as cell division and motility, and, as such, deficits in these proteins lead to devastating diseases and cancer. This project aims to provide fundamental molecular- level understanding of this critical cytoskeletal crosstalk using an interdisciplinary approach -- engineering novel, physiologically relevant assays to study the cytoskeleton’s mechanistic underpinnings using powerful biophysical tools. These findings will not only facilitate deeper understanding of the molecular mechanisms that sustain life, but also be the foundation for developing screening and diagnostic tools to better predict and treat cytoskeletal- based diseases.